MELATONIN SENSITIVITY TO LIGHT IN PREMENSTRUAL MOOD DISORDER PATIENTS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To study light pulses on circadian rhythms and to determine the role of altered human circadian pacemaker dynamics in female depressed and control populations.